Effect of Immune-Enhancing Nutrition on Radical Cystectomy Outcomes

PROJECT SUMMARY/ABSTRACT
Patients undergoing surgery to treat their bladder cancer face very high rates of complications and mortality.
The radical cystectomy operation is fraught with the highest complication rates of all urologic oncology
surgeries performed and is also extremely catabolic. As the National Cancer Institute has identified in its
provocative questions 2 & 11, variations in immune function and nutritional interventions affect the
response to cancer treatment. Radical cystectomy will continue to save lives, but there is a high cost in terms
of persistent surgical complications. The long-term goal of this project is to unlock the potential of nutrition
interventions to improve outcomes, survival, and quality of life in cancer patients. The objective of this project
is to determine the impact of a specialized form of nutritional support on surgical outcomes and to better
understand the mechanisms by which it acts. The hypothesis is that perioperative use of a specialized form of
nutritional support will have greater efficacy than a standard form of nutritional support to reduce post-
operative complications. This hypothesis has been formulated on the basis of published preliminary data
produced in the applicants' laboratories and expert guidelines calling for more rigorous study of this
approach. The rationale is that Specialized IMmunonutrition (SIM) is fortified with nutrients (L-arginine,
omega-3 fatty acids, dietary nucleotides, and vitamin A) that have immediate effects on immune and
inflammatory responses, muscle sparing, and wound healing after surgery. Guided by strong preliminary
data, the hypothesis will be tested in three specific aims: 1) To determine the impact of perioperative SIM
versus an identical Oral Nutrition Support (ONS) lacking the immuno-modulators on post-operative
complications from RC; 2) To compare the impact of SIM to ONS on secondary clinical outcomes after RC
surgery; 3) To evaluate the impact of consuming SIM compared to ONS for restraining myeloid-derived
suppressor cells (MDSCs), decreasing inflammation, and modulating nutrient metabolism. The project is
significant because it offers a high yield, low-risk, low-cost strategy to improve the outcome of patients with
bladder cancer who undergo RC. Our innovative approach could transform clinical practice to reduce post-
operative complications, thereby diminishing the burden of bladder cancer surgery and has the added
potential to help many other surgical patients beyond cystectomy.

Public health relevance
PROJECT NARRATIVE The ultimate goal of this research is to unlock the potential of nutrition interventions to improve outcomes, survival, and quality of life in cancer patients. The aims follow the National Cancer Institute's (NCI) strategic objectives to improve the quality of life for cancer patients, to address provocative questions 2 & 11, and to use the National Clinical Trials Network for a rapid translation of findings into better clinical outcomes from cancer treatment.